Supplement for Discovering and Exploiting Caspase Regulatory, Allosteric and Exosites

PROJECT SUMMARY
Caspases are cysteine proteases that control apoptotic cell death. Caspases are activated to kill cancerous
cells but, inhibiting caspases can prevent deleterious cell death in diseases like heart attack and stroke. Thus,
there has been significant interest in caspases as drug targets. This interest heightened further with the finding
that caspase-6 plays a central role in neurodegeneration. Unfortunately, no caspase-directed therapies are
on the market, primarily because work has focused on the active site, the most conserved region of the family.
It is clear that each caspase is regulated in a unique manner. A comprehensive understanding of which is
essential to achieve caspase-specific inhibition. Thus, our long-term project goal has been to define and ex-
ploit unique regulatory features for each apoptotic caspase.
Our pursuit of that goal has been successful. Due to our understanding of the unique features of each apop-
totic caspase, we developed an allosteric caspase-6 inhibitor that is more potent than any reported (33 nM)
and is also by far the most selective, preferring caspase-6 500-fold or more over all other caspases. This
selectivity was possible because the allosteric site we targeted is unique to caspase-6, locking it into a helical
conformation not attainable by any other caspase. It is gratifying that our intense and systematic study of
caspase regulation - cleavage state, conformational change, zinc binding and phosphorylation - culminated
in a structural understanding that enabled us to meet our goal of caspase-selective allosteric inhibition. We
are still working to understand the conformational transitions of caspase-6 between the helical and strand
state and to understand the impact of our caspase-6 inhibitor on that conformational equilibrium. These stud-
ies are only possible by using high-field NMR experiments. We have begun many of these studies by use of
NMR spectrometers at national facilities and the results are extremely promising. We have recently been
awarded funds from the Massachusetts Life Science Center for purchasing a new 800 MHz NMR for UMass
Amherst that is appropriate for our ongoing experiments. This will dramatically improve our ability to assess
the conformational sate of caspase-6 and ultimately of other caspases. The robust and reliable function of the
800 MHz NMR is dependent on cooling of the magnet with liquid Helium (He). Unfortunately, due to changes
in manufacturing of and availability of He-recovery systems, we are not able to purchase the expected He-
recovery system to support the functioning of the new UMass 800 MHz Bruker spectrometer and the NMR
experiments in the Hardy lab. This proposal is requests partial funding for a PICASSO He-recovery system
from Quantum Technologies Corp.

Public health relevance
Project Narrative Our work over the past two decades has focused on understanding caspase regulation at a structural level and has resulted in development of the most selective and potent caspase-6 inhibitor to date. We have recently found that NMR is essential for our understanding of this system. The goal of this supplement is to purchase a helium recovery system which will enable robust and reliable functioning of our 800 MHz NMR spectrometer while dramatically improving the environmental impact of cooling the high-field magnet.